The housing environment and ambient temperature (HEAT) study

Abstract
Without intervention, by the end of this century, extreme heat will cause tens of thousands of excess deaths.
Developing a complete understanding of the long-term burden of deaths from heat, and characteristics that
heighten or reduce heat vulnerability, is critical – for illuminating the urgency of climate change mitigation
strategies and informing the design of interventions for heat adaptation. It is well accepted that heat vulnerability
is determined by biologic susceptibility, adaptive capacity, and exposure intensity, and that most heat-related
deaths - particularly among the elderly in the United States and Europe - occur indoors. Nevertheless, current
understanding of heat-related mortality and vulnerability remains limited. First, most research on heat-related
death has quantified acute (short-term) associations between temperature and mortality; as a result, there
remains uncertainty about the long-term burden of deaths attributable to heat. Second, most research has
calculated associations with outdoor rather than indoor temperatures, thus potentially misclassifying exposures
and under-estimating the mortality impacts of heat. Additionally, little is known about the extent to which housing
interventions that promote thermal comfort, such as improving insulation or altering roofing material, may prevent
excess deaths from heat. There is an urgent need to fill these gaps, since most people, and especially heat
vulnerable subpopulations like the elderly, spend the majority of their time inside. Here, we propose a longitudinal
cohort study of a nationally representative sample of age 65 and older adult participants of the Mortality
Disparities in America Communities (MDAC) study linked with Medicare and National Death Index data. We will
combine these data with indoor temperature and humidity variables calculated using building science and
physics-based simulation models; individual-level housing characteristics derived from nationally representative
survey data; and high-resolution land cover data. We will leverage the resulting large, population-based
database, consisting of a remarkably rich set of person- and neighborhood-level variables, to improve
understanding of associations between housing characteristics, indoor temperature exposures, and mortality,
and person- and neighborhood-level determinants of heat vulnerability. In Aim 1, we will quantify associations
between summertime indoor temperature exposures and longer-term all-cause and cause-specific mortality. In
Aim 2, we will elucidate person- and neighborhood-level factors that enhance or reduce vulnerability to indoor
heat. In Aim 3, we will quantify the total excess deaths that may be prevented through housing interventions that
improve thermal comfort - under current and future climate scenarios. We will stratify all analyses by climate
zone and by urbanicity levels, to account for differences in urbanization-related heat exposures, built-
environments, and physiologic acclimatization. This impactful project will provide information that is critically
needed to guide interventions for heat adaptation.

Public health relevance
Narrative In this longitudinal study of a nationally representative sample of age 65 and older Americans, we will estimate associations between indoor heat exposures and longer-term mortality, identify person- and neighborhood- level factors that impact heat vulnerability, and quantify numbers of excess deaths from heat that may be prevented through housing interventions. Results from this work will improve understanding of the long-term burden of mortality from heat and provide critical information to guide region-specific housing intervention strategies for heat adaptation.